EGF as an environmental cue of B. burgdorferi gene regulation

PROJECT SUMMARY/ABSTRACT
Lyme disease is the most common vector borne disease in the northern hemisphere, causing nearly 500,000
cases in the United States alone each year. This disease is caused by the spirochete Borrelia burgdorferi, which
is transmitted to humans by the bite of an infected Ixodes tick. To persistently infect a host, B. burgdorferi must
transmit from a tick, colonize the initial site of infection, and disseminate to distal tissues. Each stage of the
infection cycle provides different environmental pressures, so the spirochetes undergo stage-specific
transcriptional regulation to express genes required for their survival. I have recently discovered that epidermal
growth factor (EGF) may be an environmental cue recognized by B. burgdorferi to coordinate this stage-specific
gene expression. In my preliminary data, EGF directly bound to the spirochetes and induced a B. burgdorferi
transcriptomic profile consistent with what is seen at later stages of infection. This is the first description of B.
burgdorferi directly binding to a host protein to coordinate gene expression. However, the binding of EGF to B.
burgdorferi and the resulting transcriptional regulation remains poorly characterized. Here, I aim to characterize
binding by estimating the binding kinetics and specificity with flow cytometry and surface plasmon resonance,
and by determining the spatial dynamics with immunofluorescence and electron microscopy. Further, I aim to
dissect EGF-mediated transcriptional regulation by comprehensively characterizing the B. burgdorferi
transcriptome following EGF treatment, and by identifying responsible transcription factors through the use of
transcription factor knockout B. burgdorferi strains. Overall, the work proposed here will immediately expand our
understanding of B. burgdorferi host sensing, identify a vulnerable interaction, and establish an exciting new
paradigm by which the direct binding of a host protein impacts the coordination of B. burgdorferi gene expression.
Further, it will lay the foundation for future studies to increase our understanding of Lyme disease pathogenesis,
and result in powerful new treatments and therapeutics to limit the public health burden of this disease.
Under this K22 award I will work with my mentors and collaborators to develop the expertise needed to
successfully execute the bacterial transcriptomic and imaging studies detailed here. Further, I will attend career
development workshops and work with my mentors to develop the skills needed to build my own grant-funded
research program at a leading academic institution. Overall, this proposed K22 award will provide me with the
time and structure needed to train and develop professionally so that I may meet my career goal of becoming
an independent investigator focusing on host-pathogen interactions shaping vector borne disease pathogenesis.

Public health relevance
PROJECT NARRATIVE To successfully transmit from a tick and infect a host, Lyme disease spirochetes (Borrelia burgdorferi) must sense the changing environmental cues and undergo stage-specific transcriptional regulation that is required for successful tick-to-host transmission, initial host colonization, and dissemination to distal host tissues. We have recently discovered that epidermal growth factor induces this stage-specific gene expression, and we now propose to thoroughly examine its binding to B. burgdorferi and impact on transcriptional regulation. This work will expand our understanding of B. burgdorferi host sensing, identify a vulnerable interaction that may be targetable by treatments and therapeutics, and establish an exciting new paradigm by which the direct binding of a host protein impacts the coordination of B. burgdorferi gene expression.